The Association of Pneumonia-Related Financial Toxicity with Subsequent Outcomes

PROJECT SUMMARY/ABSTRACT
Candidate’s Long-Term Career Goal: By pursuing the training plan in this F32 proposal, Dr. James W.
Womer will learn key skills in clinical epidemiology and health services research, while writing a K23 award and
ultimately becoming an independent physician-scientist designing predictive tools and interventions to help
identify and assist patients at risk for impaired recovery from respiratory illness.
Clinical Problem to be Addressed: Financial toxicity affects patients suffering from a variety of acute and
chronic conditions, and is associated with worse clinical outcomes. The prevalence and risks associated with
financial toxicity in pneumonia are not known but are likely significant.
Candidate Background: Dr. Womer is a fellow in Pulmonary and Critical Care Medicine at Johns Hopkins. He
received his MD from Temple University. To date he has published 8 original peer-reviewed manuscripts, one
as first author. He will be presenting his current work at the American Thoracic Society 2023 meeting. His
department has a strong commitment to his academic career, including placing him on a T32 grant and funding
a year-long training program in clinical investigation.
Career Development Plan: In order to achieve these goals, he proposes to develop expertise in
statistics through a combination of mentored learning, investigative research work, and formal coursework to
obtain a Master of Health Science (MHS) degree from the Johns Hopkins Bloomberg School of Public Health.
Mentors: His primary mentor is Dr. Theodore J. Iwashyna at the Johns Hopkins School of Medicine, who has
served as the primary mentor on 8 K-awards (5 of whom have transitioned to R01), including 5 individual K
awards, and as co-mentor on another 5. His co-mentor is Dr. Michelle Eakin, who has several NIH grants and
won awards for her mentorship of many fellows and junior faculty.
Aims: Using data from the Medical Expenditure Panel Survey, 1: to test whether new onset financial toxicity
due to pneumonia is associated with increased subsequent need for acute care; 2: to test whether new onset
financial toxicity due to pneumonia increases the risk of later disability.
Deliverables from Aims: His proposed Aims will lead to 3-4 publications with semiannual presentations at
institutional conferences and yearly presentations at national conferences. This proposal will constitute the
foundational work for a future K23 application to build a predictive model of which patients will suffer financial
toxicity and test the efficacy of possible interventions.

Public health relevance
PROJECT NARRATIVE Financial toxicity is the objective financial burden or subjective financial strain resulting from treatment for illness. It is prevalent in many medical conditions, both acute and chronic, and in some conditions, like cancer, it is associated with worse outcomes, but its prevalence and risks in pneumonia are currently unknown. This project will use the Medical Expenditure Panel Survey to assess the prevalence of financial toxicity in survivors of pneumonia, and test the hypotheses that financial toxicity in these patients leads to (1) greater need for future care, and (2) increased disability.